Cancer Epidemiology, Prevention and Control Program

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
CANCER EPIDEMIOLOGY, PREVENTION AND CONTROL PROGRAM – PROJECT SUMMARY/ABSTRACT
The Cancer Epidemiology, Prevention and Control (CEPC) Program plays a central role in the scientific, clinical,
and public health mission of MECC. The Program’s overarching goal is to better understand and address drivers
of cancer burden and cancer disparities in our Bronx catchment area and other vulnerable populations. Program
investigators focus on studies in human populations to determine the behavioral, environmental, and molecular
risk factors that underlie cancer etiology and outcomes, leading to studies that devise, implement and test the
effectiveness of novel interventions to promote cancer prevention, screening, treatment and supportive care.
Program members collaborate extensively with one another and with the other three MECC research programs.
Given the inter- and trans-disciplinary nature of this program, CEPC is the focal point for translating laboratory-
based research into population level studies and for bridging findings from clinical and community settings back
to the lab. CEPC has three specific aims: (1) to characterize the risk factors that drive cancer health disparities
in our catchment area, most notably breast, lung, prostate, and cervical cancer; (2) to improve cancer prevention
and screening among vulnerable and high-risk groups in our catchment area and beyond; and (3) to develop
and implement innovative strategies to enhance cancer care outcomes. CEPC research has contributed to
improved health of the largely poor and minoritized Bronx population, as well as populations worldwide.
Completed and ongoing research in CEPC has substantively influenced clinical guidelines and public health
practice, with new studies poised to continue this trend. CEPC research: (i) has identified novel susceptibility
markers for breast cancer, prostate cancer, CRC, and lung cancer in non-smokers -- the major causes of cancer
mortality in the Bronx – demonstrating efforts to understand the mechanisms of cancer in an environmental and
behavioral context; (ii) contributed to major policy decisions regarding cancer care of firefighters who worked at
the 9/11 WTC; (iii) developed innovative in-reach and outreach strategies that overcome social determinants to
increase early detection and timely access to care; (iv) developed effective tobacco smoking interventions that
have been integrated in to standard clinical practice, as well as in clinical guidelines for persons living with HIV;
(v) implemented comprehensive cervical cancer screening and treatment in Western Africa; and (vi) introduced
a novel appraisal paradigm that emphasizes patients’ own personal criteria for quality of life.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward CANCER EPIDEMIOLOGY, PREVENTION AND CONTROL PROGRAM - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page